Engineering Bacteriophage T4 as a Targeted Gene Therapy Drug for in vivo HIV Cure

This proposal aims to establish a new category of safe and affordable in vivo HIV cure “drugs” that would
transform the health of substance users who are disproportionately affected by HIV-1 (HIV) disease. Substance
users suffer from high rates of HIV acquisition and transmission, poor adherence to antiretrovirals and drug
resistance, and high prevalence of neurodegenerative and mental health problems. It will also be broadly
transformative to more than 40 million people across the globe who are living with HIV today.
Using a unique bacteriophage (phage) T4 artificial viral vector (T4-AVV) technology we have recently
developed, we will engineer the 120 x 86 nm T4 capsid nanoparticle to target patient's hematopoietic stem cells
(HSCs) in vivo and deliver a payload of genome modification molecules. These will introduce a delta-32 deletion
mutation into the CCR5 HIV co-receptor gene, which will make the HSCs and the cells derived from it, HIV-
resistant. This is the only known HIV cure option today, as evident from at least five independent HIV cure cases
worldwide, all remarkably involving transplanted HSCs containing the naturally present delta-32 mutation.
Our experimental path involves three milestones. First, we will identify targeting ligands that have high affinity
and binding specificity to HSCs from human umbilical cord blood (UCB). These will be selected from libraries of
nanobodies, darpins, and ScFvs displayed on phage T4 capsid through fusion at the tip of the 180Å-long,
flexible, outer fibers known as Hoc. Next, HSC-targeting, lipid-coated, T4-AVVs will be assembled in the test
tube by incorporating all the HIV cure molecules into one nanoparticle by sequential assembly and DNA
packaging. These include combinations of genome editing enzymes, gRNAs, and donor DNAs. The T4-AVVs
that exhibit maximum delta-32 genome conversion will be optimized using an ex vivo UCB-HSC model. Finally,
the HSC-targeted T4-AVVs will be tested in vivo in a humanized DRAGA mouse model reconstituted with the
same UCB-HSCs, using a protocol that mimics HIV cure in humans. Various parameters will be optimized such
that the T4-AVVs will enter HSCs in minutes, deliver payload in hours, and modify genome in 1-2 days.
The T4-AVV in vivo HIV-cure would be a safe, affordable, outpatient protocol that can be easily administered
to substance users. Since it is targeted, a small dose of T4-AVVs (~10E12 particles) would be sufficient to
capture the HSCs mobilized into patient's blood, while minimizing host immune responses and off-target events.
The delta-32 converted HSCs will then repopulate the body with HIV-resistant blood cells including CD4+ T cells,
which would replace the HIV reservoir and result in functional HIV cure. A single dose of T4-AVVs might be
sufficient, however a second dose may be needed to maximize HSC delta-32 conversion for permanent HIV
cure. Currently, T4-AVV is the only technology that has the capacity and engineering capability to create such
HIV cure delivery vehicles. Furthermore, this plug-and-play drug model can be adapted to many other blood cell
diseases and cancer, potentially transforming future gene therapies and precision medicine.

Public health relevance
PROJECT NARRATIVE More than 40 million people across the globe are now living with HIV-1, of which the substance users constitute a disproportionate and “key population”, yet there is no cure or vaccine on the horizon. Using our recently developed bacteriophage T4 artificial virus vector technology, this proposal will establish a novel and affordable in vivo HIV cure platform that can be easily administered to substance users through one or two infusions. The HIV cure “drug” will target stem cells and introduce genetic modifications that confer resistance to HIV infection and then, by repopulating the body with HIV-resistant blood cells including resistant T cells, it replaces the HIV reservoir and leads to functional HIV cure.